Neurobiology of Language Re-learning in Post Stroke Aphasia Treatment

Aphasia is a debilitating language disorder that affects over 2 million Americans1 and impairs communication
and reduces quality of life. Behavioral language treatment protocols are the clinical standard for managing
aphasia. These interventions aim to restore language functions through structured therapy. However, treatment
outcomes vary widely2,3, and the mechanisms underlying treatment success remain unclear. Prior studies have
identified several non-modifiable predictors of aphasia recovery, such as initial aphasia severity and lesion
characteristics3,4. However, there are additional modifiable factors that may contribute to aphasia treatment
response which have yet to be studied. Sleep-related memory consolidation may be one such factor. Sleep is
required to stabilize labile memory traces for long-term retention, and its disruption impairs learning5. Stroke
survivors frequently experience sleep disturbances6, but the impact of these disturbances on aphasia
treatment outcomes has not been systematically evaluated.
This project applies relevant principles of the Complementary Learning Systems (CLS) neurobiological
framework to aphasia treatment as a model for understanding the contribution of sleep to aphasia treatment
outcomes. The CLS is a dual systems model of learning that describes a division of labor between brain
systems to support learning, in which newly learned information is initially stored in the hippocampus and is
gradually consolidated to rely more on stable neocortical brain networks for long-term retention7,8. Sleep
facilitates this hippocampal-to-neocortical shift, but it is unknown how well the core principles of CLS are
upheld in the lesioned brains of individuals with aphasia. We will extend the relevant principles of the CLS
framework to evaluate how sleep-related consolidation influences neural and behavioral response to aphasia
treatment.
Specific Aim 1 explores the role of sleep in behavioral and neural treatment outcomes by associating sleep
quality with changes in naming performance and brain activation. Specific Aim 2 tests whether aphasia
treatment promotes shifts in brain activation patterns in hippocampus and neocortex, and how these shifts are
associated with behavioral improvements. Data from an ongoing clinical trial of intensive naming treatment will
be used to address these aims. Data collection for this trial will be complete prior to beginning the proposed
project. This study represents the first systematic investigation of sleep’s impact on aphasia treatment as well
as a novel application of a neurobiological framework of learning to aphasia recovery. Findings could uncover
modifiable mechanisms driving treatment-response variability, identifying new pathways for optimizing patient
outcomes. Completing this research project and the associated training, the applicant will develop essential
expertise, establishing herself as the first cognitive neuroscientist specialized in sleep and aphasia recovery.

Public health relevance
PROJECT NARRATIVE Aphasia is a language disorder affecting over 2 million people in the U.S. that often leads to debilitating communication deficits with highly variable treatment outcomes. Sleep plays a critical role in memory consolidation, yet its impact on language re-learning during aphasia treatment is poorly understood. This study will investigate how sleep-related consolidation influences treatment outcomes by examining the relationship between sleep quality, brain activation patterns, and naming improvements in individuals with aphasia.